Mitochondrial network remodeling and the glutamine-proline axis in pulmonary vascular disease associated with CHD.

Project Summary (Project #3)
Pulmonary vascular disease (PVD) in infants and children with congenital heart defects (CHD) causes significant
morbidity due to increased pulmonary blood flow and pressure. A major challenge in treating these patients is
the limited mechanistic understanding of endothelial dysfunction in CHD-associated PVD. In the current research
cycle, Project #3 identified that disruptions in mitochondrial network dynamics, specifically an imbalance between
mitochondrial fission and fusion, play a critical role in metabolic reprogramming, leading to endothelial
dysfunction. Increased mitochondrial fission, driven by dynamin related protein 1 (Drp1), shifts the metabolism
toward a Warburg phenotype, while the loss of the fusion protein mitofusin-2 (MFN2) plays a significant role in
suppressing fusion and maintaining elevated glycolysis. These changes promote glutamine-proline metabolism,
collagen biosynthesis, cell proliferation, and survival, further driving endothelial dysfunction and proximal
pulmonary artery (PA) stiffness. New findings indicate that the JNK-Huwe1 axis contributes to MFN2
degradation, disrupting mitochondrial network dynamics and promoting the angiogenic phenotype in pulmonary
artery endothelial cells (PAEC). The research plan aims to investigate the mechanisms behind JNK-mediated
MFN2 degradation, its effects on mitochondrial function and metabolic reprogramming, and its role in endothelial
dysfunction. The study will explore how JNK activation leads to the proteasomal degradation of MFN2 via Huwe1,
and how this process disrupts mitochondrial dynamics and rewires cellular metabolism. In addition, the
therapeutic potential of targeting mitochondrial dynamics to restore endothelial function will be assessed. The
research will explore strategies to prevent MFN2 degradation using Huwe1 inhibitors and attenuate mitochondrial
fission using a novel Drp1 inhibitor developed by us. These therapeutic approaches will be tested in lamb models
of CHD-PVD, with the goal of reversing metabolic reprogramming, improving endothelial function, and reducing
pulmonary vascular remodeling. Ultimately, this project aims to uncover novel regulatory mechanisms and
therapeutic targets to improve outcomes for children with CHD-associated PVD.

Public health relevance
Project Narrative (Project #3) The incidence of congenital heart defects in the U.S. is ~1 per 100 live births, and approximately 50% of these children require medical and/or surgical attention. Although survival for these children has improved, they continue to suffer significant morbidity and late mortality, in part because of abnormal vascular reactivity within their lungs. Our studies are designed to increase our understanding of the mitochondrial network dynamics in this process, which could improve the survival of children born with congenital heart defects.